Task A08: Collection of Metadata from In Vivo Studies Performed Under Previous IDIQ Contract Mechanisms

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.